A pilot to develop and test an Interactive Computer-adaptive Chronic Kidney Disease education program for hospitalized African American patients (I-C-CKD)

PROJECT SUMMARY
African Americans with chronic kidney disease (CKD) experience disparities in the quality of their medical care,
self-care and preparation for end stage renal disease (ESRD). Patient education can help African American
patients with advanced CKD decide to engage in self-care to delay progression to ESRD and to learn about
ESRD treatment options. Hospitalization represents a “missed opportunity” to provide CKD education and
ESRD planning to help patients make informed choices about their care that align with their preferences. Many
patients are hospitalized within three months of dialysis initiation. The hospital also captures patients who are
not otherwise well-linked to the medical system. In prior work, our team developed and implemented a
culturally-tailored, multi-modality patient education intervention for hospitalized African American patients with
advanced CKD using a racially concordant in-person educator and literacy-sensitive education materials. Our
intervention was feasible and effective. However, using an in-person patient educator is resource-intensive. In
this proposal, we will develop an interactive, computer adaptive patient education intervention that benefits
from the convenience of electronic media with the patient-centered benefits of an in-person educator. We will
also determine the efficacy of the computer-adaptive education in improving knowledge for hospitalized African
American patients with advanced chronic CKD as compared to usual care. We have assembled a strong team
with skills in chronic kidney disease health disparities, hospital-based interventions, culturally-tailored patient-
education, motivational interviewing, and technology-based interventions for patient education. This R21 pilot
and feasibility trial will enable the team to build and test the efficacy and acceptability of the computer-adaptive
education intervention prior to a larger scale randomized R01-level study.

Public health relevance
PROJECT NARRATIVE Patient education can help African-Americans with advanced chronic kidney disease (CKD) make informed decisions about their healthcare; such decisions impact self-care behaviors, which can subsequently delay progression to end stage renal disease (ESRD), and also determine how and when patients choose ESRD treatments. This proposal seeks to develop and evaluate a novel computer-adaptive patient-centered referral and education program for hospitalized African-American patients with advanced CKD. The data from this study will be critical for the development of future R01 proposals to assess the cost-effectiveness and impact on clinical and public health outcomes of this approach to education and referral for patients with advanced CKD and ESRD.